Advanced Delivery Platforms for Base Editing In Vivo

Project Summary
The Cas9 platform has enabled genome editing, base editing (BE), and prime editing to induce gene
knockouts as well as tailor-made sequence alterations. CRISPR-Cas9 systems have the potential to similarly
revolutionize clinical practice through precise editing of disease loci. We have developed Nme2Cas9 as an
editing platform with (1) compact size, facilitating single adeno-associated virus (AAV) delivery; (2) a
dinucleotide (N4CC) protospacer-adjacent motif (PAM) that affords high target site density; and (3) exceptional
accuracy. More recently, we developed Nme2Cas9 adenine base editor (ABE) systems as among the first to
be validated in vivo for single-AAV delivery. AAV is a potent editing delivery modality in vivo, especially in
extrahepatic tissues such as the central nervous system (CNS). Nonetheless, the therapeutic promise of base
editing systems will hinge upon improving editing efficiency, limiting bystander edits (or their consequences),
maximizing PAM-dependent targeting scope, and minimizing immunogenicity, toxicity, and prolonged
deaminase expression (which can compromise editing efficiency and lead to safety risks such as hepatotoxicity
and the accumulation of unwanted edits). Here we propose to capitalize on our establishment of single-vector
Nme2-ABE systems to develop novel base editing capabilities with increased effectiveness, targeting scope,
utility, and safety, and to validate these systems in the treatment of CNS disease models in mice. The goals of
this proposal are (1) to develop next-generation, single-AAV, deaminase-inlaid Nme2-ABEs and guides with
increased efficiency, a single-nucleotide PAM, and greater control over bystander editing; (2) to use next-
generation, single-AAV Nme2-ABE systems for therapeutic editing of disease genes in the CNS of mouse
models of amyotrophic lateral sclerosis and Batten disease; and (3) to develop systems that use repression by
endogenous microRNAs and drug-dependent splicing systems to enhance the safety of AAV-delivered Nme2-
ABE in vivo. These safety enhancements will reduce anti-Nme2-ABE immune responses, ameliorate potential
toxic effects on the liver and on specific CNS cell types, and limit the off-target mutagenesis that can arise from
sustained expression of the editing machinery. Successful completion of these aims will provide invaluable
enhancements to the delivery, efficacy, and specificity of in vivo genome editing.

Public health relevance
Project Narrative Challenges with delivery, specificity, and immunogenicity in current gene editing technologies have hindered efforts to correct genetic disease mutations in vivo, especially beyond the liver. This proposal seeks to develop and validate new base editors, delivery vehicles, and safety enhancements, and to apply them to mouse models of central nervous system disease. These studies will enhance the efficacy and safety of in vivo genome editing capabilities of base editors and other CRISPR tools.